Inter Organ Crosstalk in Non-Alcoholic Steatohepatitis (NASH)

ABSTRACT Support is requested for a Keystone Symposia conference entitled Inter Organ Crosstalk in Non-Alcoholic Steatohepatitis (NASH), organized by Drs. Greg Steinberg, Camilla Charlotte Schéele and Saswata Talukdar. The conference will be held in Keystone, Colorado from February 6-9, 2022. The epidemics of obesity and type 2 diabetes are driving the development of non-alcoholic steatohepatitis (NASH) which is rapidly accelerating rates of liver cirrhosis and hepatocellar carcinoma (HCC). NASH is characterized by complex crosstalk between different cell types and organ systems that leads to steatosis, inflammation and fibrosis. This intracellular communication involves multiple cells types within the microenvironment (e.g., stellate cells, macrophages, T cells and hepatocytes) but also includes interactions with multiple organ systems (e.g., gut microbiome, brown/beige/white adipose tissue and muscle). With the development of many new technological advances (e.g., proteomics, single cell RNAseq, and organoids), our understanding of these intricate signaling pathways is rapidly expanding. The conference will bring scientists across different disciplines together to provide a forum for sharing rapidly emerging methodological advances in order to understand the mechanisms by which cells and organ systems communicate, in order to develop new paradigms and therapeutic strategies for the treatment of NASH. Given the importance of adipose tissue as a critical storage depot, an endocrine organ, and a regulator of energy expenditure, this conference will be held jointly with the Keystone Symposia meeting Adipose Tissue and Metabolic Health in order to expand opportunities for interdisciplinary interactions.

Public health relevance
PROJECT NARRATIVE The epidemics of obesity and type 2 diabetes have contributed to alarming increases in non-alcoholic fatty liver disease (NAFLD) and non-alcoholic steatohepatitis (NASH), which is now the major cause of liver cirrhosis and hepatocellular carcinoma (HCC). Attendees of this conference will gain a holistic understanding of the unmet needs in NASH/NAFLD and discover new paths to advancing our understanding NASH pathogenesis, diagnosis and therapy. By bringing together researchers with a wide spectrum of perspectives from academia and pharma/biotech, this conference aims to significantly advance the field and to benefit human health.